PBRM1 bromodomain missense mutations in ccRCC vascular signaling

PROJECT SUMMARY
Clear cell renal cell carcinoma (ccRCC) is the most common subtype of renal cell carcinoma. Although
outcomes are favorable with early detection and surgery, approximately 30% of patients present with
metastatic disease. This highlights the need for an improved biochemical understanding of and targeted
therapeutic options for ccRCC. ccRCC is a uniquely vascular cancer due to mutations in the von Hippel-Lindau
(VHL) gene, which encodes the substrate recognition subunit of a ubiquitin ligase that degrades hypoxia-
inducible factor-α (HIF-α) transcription factors in normoxia. VHL loss results in nuclear HIF-α accumulation and
aberrant expression of downstream pro-angiogenic gene targets in a likely HIF-2α-biased manner. Thus,
ccRCC tumors are uniquely susceptible to anti-angiogenic therapies, which though effective, are associated
with substantial undesirable toxicities for patients. Recent clinical trials have demonstrated that mutations in
Polybromo-1 (PBRM1), an epigenetic acetyl-lysine reader protein commonly mutated in ccRCC, correlate with
improved outcomes for anti-angiogenic therapies. However, these studies presume that all PBRM1 mutations
are loss-of-function and neglect to consider that ~15% of ccRCC-related PBRM1 mutations are missense
mutations, generating full-length proteins with a spectrum of undetermined structural and functional impacts.
ccRCC-associated PBRM1 missense mutations cluster in bromodomains (BDs), the functional domains of
PBRM1 that bind acetyl-lysine residues in histones and other nuclear proteins and nucleic acids. Therefore, a
better knowledge of the biochemical impacts of PBRM1 BD missense mutations in ccRCC is critical to promote
PBRM1 as a predictive biomarker for patient response to anti-antiangiogenic therapies, so that non-responding
patients can avoid unnecessary therapeutic toxicity and seek alternative treatments. This fellowship will
elucidate the biochemical impacts of ccRCC-associated PBRM1 BD missense mutations on protein stability
and acetylated histone binding function and determine the role of PBRM1 in the regulation of the HIF-2α and
angiogenesis pathways. Aim 1 will identify which PBRM1 BD missense mutations are biochemically benign or
deleterious for protein structure and function by integrating computational prediction with biophysical assay
validation. Aim 2 will determine the effects of PBRM1 BD missense mutations on HIF-2α and angiogenesis
pathway regulation by assessing HIF-2α transcriptional output, HIF-2α promoter accessibility, and angiogenic
potential in ccRCC cellular assays. This fellowship addresses knowledge gaps in the biochemical basis of
ccRCC pathogenesis with the overall goal to promote the most effective use of standard ccRCC treatment
modalities. Successful completion of this fellowship will further precision medicine approaches for the
treatment of ccRCC by advancing PBRM1 mutational status as a nuanced and predictive biomarker to prevent
unnecessary patient drug exposures.

Public health relevance
PROJECT NARRATIVE Clear cell renal cell carcinoma (ccRCC) is a type of cancer characterized by tumors whose growth relies on making new blood vessels, and therefore, ccRCC responds well to drugs that prevent new blood vessels from being made. ccRCC-associated mutations in a DNA-binding protein called PBRM1 improve patient response to these drugs that prevent tumor blood vessel formation, but mutations that do not inhibit PBRM1 activity are common, and the effects of these mutations on patient drug response are unknown. We will determine how mutations that do not disrupt PBRM1 activity affect how ccRCC tumors increase their blood supply so that patients who will not respond are not unnecessarily given drugs with toxic side effects.